Epigenetic Regulation in Human Embryonic Stem Cell Lineage Specification

Embryonic development is a complex and intricately timed process such that any deviation from the correct
sequence of events can elicit unwanted developmental effects. Epigenetic mechanisms, like DNA methylation
and microRNAs (miRNAs), have a crucial role in development, impacting gene expression in the cell necessary
for tissue-specific gene expression, gene-environment interactions, differentiation, and growth. Human
embryonic stem cells (hESCs) have helped our understanding of mechanisms involved in development and
disease. Yet, the epigenetic factors involved in early hESC differentiation before specialized cell types need
further understanding. My research program seeks to investigate the relationship between DNA methylation and
miRNAs during early hESC lineage specification. We will dissect early cell fate changes due to epigenetic
regulation using various omics technologies, cell imaging, and transcriptional regulator expression changes. We
will explore the interplay between DNA methylation and miRNAs to regulate gene expression during normal and
abnormal differentiation. In addition, we will answer questions about the most suitable methods for directed
differentiation and cell state identity, such as determining the cell makeup in a pan-mesoderm differentiation
approach and using methods that differentiate cells through a specific mesoderm subtype. We are excited about
the proposed work and believe our projects will contribute to understanding of embryogenesis, stem cell biology,
and identifying epigenetic factors leveraged as biomarkers of aberrant embryonic development.

Public health relevance
Our research aims to understand the epigenetic mechanisms that regulate human embryonic development. The proposal uses human embryonic stem cells to determine how DNA methylation and microRNAs regulate neural crest and mesoderm lineage specification. The results of this study will impact our understanding of human neural crest and mesoderm-related disorders, like congenital disabilities, caused by uncharacteristic epigenetic mechanisms.